Los Angeles Area Health Services Research Training Program

PROJECT SUMMARY
The Department of Health Policy and Management at the UCLA Fielding School of Public Health, in
collaboration with RAND Health, the Schaeffer Center for Health Economics at the University of Southern
California, and the Veterans Administration Center for the Study of Healthcare Innovation, Implementation and
Policy, proposes the renewal of its pre- and postdoctoral training grant, which has had an outstanding record of
producing the next generation of scholars over the past 30 years. The goal of the Los Angeles Area Health
Services Research Training Program is to provide comprehensive training and experience to highly-qualified
pre- and postdoctoral trainees, so that they may effectively engage in, and ultimately lead, research and
implementation activities aimed at improving the quality and efficiency of the U.S. health care system, and be
able to effectively inform both public and private policymakers how to design and assess such activities and
changes. Taking advantage of the expertise of faculty and researchers at these institutions – over three dozen
of whom have agreed to be mentors – as well as a track-record of community involvement in the Los Angeles
area, the Training Program focuses on several key research topics in which the collaboration has particular
expertise: insurance, payment, and health system change; implementation, improvement science, and learning
health systems; patient, provider, and organizational decision-making; health outcomes measurement; health
equity; community-oriented population health; and health services outside of the clinic. Predoctoral trainees will
complete the PhD curriculum and requirements in the UCLA Department of Health Policy and Management.
The PhD program is designed to provide high-level methodological skills and applied training, with depth in
study design and evaluation, statistics/econometrics, and applications to the health care sector. Moreover,
each student is required to choose a cognate (examples include economics, sociology, public policy,
organizational behavior, and health care outcomes research) in which they take additional courses that
develop competencies in cognate-related theory, conceptual models and research methods. The postdoctoral
program will provide individualized training plans for postdoctoral trainees. Unlike many such programs in the
sciences, trainees are not assigned to work on particular projects. Upon entry into the program, they meet
individually with key faculty involved in the Training Program at the four collaborating institutions so that they
can learn about the opportunities in each institution and choose appropriate mentors and projects. During their
postdoctoral experience, they collaborate with the program's faculty and researchers, develop their own
research, submit journal articles, and write grant proposals to help facilitate their move to their next
professional position.

Public health relevance
PROJECT NARRATIVE COVID-19 has highlighted many of the finest and poorest aspects of the U.S. health care system - new vaccines were developed and delivered in record time through joint public-private partnerships, but there have been huge inequities in hospitalization and mortality rates among racial minoritized groups. The pandemic also highlighted a lack of preparedness: having a sufficient number of well-trained public health workers who can be mobilized on short notice as well as a sufficient stockpile of equipment such as surgical-quality masks. The proposed training program will make significant and distinctive contributions to the field by shepherding new scholars who will work in academia, research organizations, health care delivery systems and industry research groups to address this and many other of the country’s ongoing health and healthcare challenges.